Hair Bundle Proteins

Project Summary
The long-term goal of our laboratory is to determine how a hair cell assembles and operate its mechanically
sensitive hair bundle, and to determine how defects in genes responsible for bundle structure and function lead
to deafness. In this project, we propose to finally accomplish biochemical purification of the hair cell’s
transduction complex, the assembly of proteins—including the transduction channel itself—that mediates the
mechanical-to-electrical transduction that is the key event in hearing and balance. In addition, as recent
evidence has shown that Ca2+ entry through transduction channels fine-tunes stereocilia length and hence
perfects the stereocilia staircase, we will purify the protein complexes that control stereocilia dimensions and
determine whether they are regulated by transduction through Ca2+ entry. Finally, we will expand our
computational model for tip-link regeneration to include stereocilia length regulation, with the goal of simulating
the process of final adjustment of the stereocilia staircase. Predictions of this model will be tested in by
examining tip links and stereocilia length in the chick cochlea, a robust experimental system for examining hair-
bundle development. This project uses advanced biochemical purification techniques, including a new method
for elution from immunoaffinity columns that allows sequential antibody purification steps without the use of
harsh conditions. We also continue to pioneer the application of high sensitivity mass spectrometry methods
for identifying and quantifying proteins in the inner ear. Even though the number of hair cells is limited in the
inner ear and the molecules mediating transduction and stereocilia length regulation are scarce, these
sensitive methods allow us to use a biochemical approach to investigate these processes. We expect that this
project will determine the molecular composition of the transduction apparatus, including stoichiometry of the
constituent proteins, and to define the steps in stereocilia dimension regulation that are controlled by Ca2+. Our
computational model for transduction’s fine-tuning of stereocilia length should then set the stage for a future
comprehensive model that can describe assembly of the hair bundle and its transduction apparatus.

Public health relevance
Project Narrative: Public Health Relevance Hearing loss is a major health problem that significantly affects the life quality of affected individuals. Many forms of hearing loss arise from damage to hair cells, the cells that convert vibrations from sound or accelerations from head movements into electrical signals. We propose here to identify components of the machinery that regulates hair cell development and function, and show how those components interact to make the machinery mechanically sensitive.